Core 2: Bioinformatics/Biostatistics/Genomics

CORE 2 PROJECT SUMMARY
Key to this proposal is the inclusion of Core 2, which encompasses unified support for Bioinformatics,
Biostatistics, Genomics, Transcriptomics, and Computational Biology and the development of an integrated
analytical platform that will consolidate all the computational methods and tools developed or adapted to
accomplish each of the projects’ research agendas. Core 2 will provide support for both exploratory and
hypothesis-free analyses as well as for hypothesis-driven targeted identification of the molecules and pathways
identified in the research programs of each of the three projects. For example, a detailed analysis of the
sequencing data generated by the projects will reveal the changes in the somatic mutations, driver mutations,
clonal evolution, and mutational signatures due to hypernutrition and metabolic stress. This core will also
maintain a database linking all the biospecimens, organoids, PDOXs, and the associated data from all projects
and cores. As the different projects generate data, this core will integrate the data with analysis modalities to
identify, e.g., novel pathways and cross-talk between NRF2, ATF6, SAB, and other identified biomarkers.

Public health relevance
PROJECT NARRATIVE – CORE 2 Core 2, Bioinformatics / Biostatistics / Genomics Core will provide unified support and consolidation of all the Bioinformatics, Biostatistics, Genomics, Transcriptomics, and Computational Biology relevant to the to the projects. These tools and resources will be made available to the Cancer Research community and will be useful to researchers working in the field and to perform similar analyses in other cancer and conditions.